The role of Angiopoietin-like 4 in clear cell renal cell carcinoma and its therapeutic potential

Project Summary
Renal cell carcinomas (RCC) are the 7th most common types of cancer in the world with over 400,000 new cases
and 170,000 deaths worldwide each year. Clear cell renal cell carcinomas (ccRCC) are the most common
(>80%) and most aggressive subtype of RCC. ccRCC are highly vascularized tumors with elevated levels of
vascular endothelial growth factor A (VEGFA) due to frequent (>80%) loss of function the Van Hippel Landau
gene. As such, the first line of therapy for ccRCC are tyrosine kinase inhibitors (TKIs) which target the VEGF
pathway in combination with immune checkpoint inhibitors (ICIs). However, these therapies have shown to be
effective in only a subset of patients. This highlights the need to identify which patient cohorts are likely to
respond and to develop novel therapies to improve the efficacy of ICIs. Angiopoietin-like 4 (ANGPTL4) is a
secreted protein with several functions including regulating angiogenesis and has been shown to promote breast
cancer progression and metastasis. We found that ANGPTL4 is highly upregulated in ccRCC compared to
normal kidney tissue and blocking ANGPTL4 or knockout of ANGPTL4 reduces tumor growth in a 786O ccRCC
xenograft model. Knockout of ANGPTL4 also decreased tumor angiogenesis and increased expression of
adhesion molecules on tumor associated endothelial cells – an indicator of vessel normalization which is a key
mechanism for combination with ICIs. We also found that a subset of ccRCC patients express low levels of
ANGPTL4 and these patients have a shorter overall survival and less frequency of VHL mutations. Correlated
with this we found that knockout of ANGPTL4 in ccRCC cells with wild type VHL increased tumor growth while
blocking antibodies against secreted ANGPTL4 had no effect. This indicates a cancer cell intrinsic function for
ANGPTL4 that is relevant to this subset of ccRCC patient. Based on these findings, we hypothesize that
ANGPTL4 has a dichotomous function in ccRCC where secreted ANGPTL4 promotes angiogenesis and tumor
progression and cancer cell intrinsic ANGPTL4 suppresses tumor growth possibly through regulation of lipid
metabolism. Targeting secreted ANGPTL4 in the tumor microenvironment in combination with ICIs is a rational
therapeutic approach for treating ccRCC patients with high levels of ANGPTL4. The objective of specific Aim 1
is to define the role of ANGPTL4 in the tumor microenvironment in ccRCC progression, metastasis and tumor
vascularization. The goal of Aim 2 is to use mouse models of ccRCC to preclinically test the efficacy of combining
anti ANGPTL4 antibodies with immune checkpoint inhibitors. In Aim 3 we will determine the cancer cell intrinsic
function of ANGPTL4 in ccRCC cell lines in regards to regulation of lipid metabolism. This project will establish
the mechanistic role of ANGPTL4 in the pathophysiology of ccRCC and its potential as a therapeutic target in
combination with immune checkpoint inhibitors.

Public health relevance
Project Narrative The proposed research aims to determine the role of angiopoietin-like 4 (ANGPTL4) in clear cell renal cell carcinoma (ccRCC) progression and its potential as a therapeutic target in combination with immune checkpoint inhibitors. We have found that ANGPTL4 is highly expressed in ccRCC compared to normal kidney that secreted ANGPTL4 can promote angiogenesis, irregular vascularization and tumor progression, while cancer cell intrinsic ANGPTL4 can suppress tumor growth possibly via regulating lipid metabolism. Using humanized mice and immune competent mouse models of ccRCC we will test the efficacy of targeting ANGPTL4 in the tumor microenvironment in combination with immune checkpoint inhibitors.